Topical nitrite reverses nitroglycerin tolerance.

PROJECT SUMMARY
Nitroglycerin (NTG) has been the first-line medication for treating angina for the past 150 years.
However, the clinical utility of NTG is greatly limited by its loss of efficacy upon repeated use, i.e. `NTG
tolerance'. Recent advances in understanding the mechanism underlying NTG-mediated vasodilation have
led to the discovery that the tolerance phenomenon can be eliminated by concomitant administration of
nitrite together with NTG. Leveraging this discovery, NANOS, Inc. has patented the method of co-
administration of NTG and nitrite and will use it to improve and expand the therapeutic use of NTG.
Our experiments in rats demonstrate that intra-peritoneal injection of nitrite eliminates NTG tolerance
induced by repeated application of NTG transdermal patches. Nitrite, an endogenous molecule which is also
FDA-approved for human use, has high safety margins and numerous cardiovascular benefits that are
attributed to its ability to increase nitric oxide bioavailability. We hypothesize that a topical nitrite
ointment will avert nitroglycerin tolerance in rodents and swine. Our long-term goal is to develop
an easy-to-use transdermal patch product for the combined application of nitrite and NTG that averts the
problem of NTG tolerance in patients. The objective of this proposal is to establish the feasibility
and efficacy of topical nitrite application for this purpose in rats and pigs.
First, we will formulate an ointment for topical application of nitrite. Topically applied nitrite dissolved
in aqueous buffer readily crosses the skin into the bloodstream, where it decays with a half-life of 30 min.
We will develop a water-in-oil (W/O) ointment to enable slow uptake of topical nitrite into the circulation to
prolong its therapeutic effects, and determine its physicochemical and biopharmaceutical parameters.
Second, we will induce NTG tolerance in rats by repeated application of NTG patches and subsequently
measure the dilatory response of coronary arteries to acute doses of NTG, both in vivo via ultrasound
measurements and ex vivo via Langendorff perfusion of isolated hearts. We will determine the time- and
dose-dependent effects of nitrite on eliminating NTG tolerance and correlate it with pharmacokinetic (PK)
parameters of nitrite measured in plasma. Third, we will measure coronary artery dilatory responses to
NTG infusion in pigs via surgical instrumentation. We will confirm the efficacy of topical nitrite ointment at
reversing nitroglycerin tolerance in pigs and determine the toxicity and PK of the nitrite ointment.
Completion of this project will generate requisite proof-of-concept data for clinical development of a
combined NTG/nitrite formulation that will resolve the century-old problem of nitroglycerin tolerance.

Public health relevance
PROJECT NARRATIVE Nitroglycerin is one of the most widely prescribed medications in the U.S., but its clinical use is often limited by the development of tolerance upon repeated administration. Building on a novel understanding of the mechanism underlying nitroglycerin-mediated vasodilation, we propose that co-administration of nitrite can prevent this tolerance. This project will test this concept in rodents and pigs using a novel nitrite ointment, with the eventual goal of improving and expanding the clinical application of nitroglycerin.